Tethosomes: a non-viral DNA platform for durable expression of therapeutic transgenes in specific target cells

Abstract
Engage Bio is developing the Tethosome platform, a non-viral strategy for the delivery and potent expression of
transgenes in target cells. Gene therapy offers the potential to treat many currently incurable heritable or acquired
diseases. While non-viral gene delivery systems are of high interest due to their redosing capability and
manufacturability, several challenges remain. mRNA-based approaches offer high peak expression but have
limited tissue specificity and short duration. In contrast, non-viral DNA-based approaches achieve long
expression duration, but are limited by low target cell delivery, low expression, and potentially dangerous or
lethal innate immune activation. Thus, there remains a need for improved technologies able to achieve high peak
expression levels for extended durations and with tissue or tumor selectivity. Engage Bio’s Tethosome platform
addresses this need by increasing non-viral delivery of DNA to the nucleus, thus increasing the level of transgene
expression. The system is comprised of 1) an mRNA encoding a proprietary DNA binding protein, and 2) a non-
viral, recombinant therapeutic DNA expression vector containing a transgene. These are packaged in a lipid
nanoparticle for co-formulation and delivery. Inside the cell, the DNA binding protein is translated and binds to
the expression vector, shuttling it to the nucleus while evading detection by innate immune sensors. Once the
Tethosome complex enters the nucleus, the DNA binding protein anchors the expression vector to the nucleus,
supporting high expression levels for extended durations without significant DNA integration or replication.
To demonstrate the potential of the Tethosome system, Engage Bio will evaluate the hepatic delivery of
therapeutics for hemophilia and liver cancer. Hemophilia A is a prototypical gene therapy candidate due to its
well-understood monogenic root: lack of FVIII. There are several adeno-associated viral vector-based therapies
in various stages of clinical study, but these suffer from the cytotoxicity, immunogenicity, and lack of re-dosability.
Moreover, traditional non-viral gene therapies for liver cancer suffer from low efficiency, short duration, and off-
target effects. To advance Engage Bio’s system and validate the durable, tissue-specific expression of
transgenes, the following Specific Aims are proposed: 1. The delivery of Tethosomes encoding a cocktail of
clinically validated pro-inflammatory cytokines (IL-2, GM-CSF, IL-15su [sushi], IL-12sc [single chain]) will be
evaluated in a humanized mouse model of hepatocellular carcinoma to demonstrate efficacy. Further, the safety
and efficacy of Tethosomes encoding FVIII will be evaluated in a canine model of hemophilia; 2. The safety of
the Tethosome platform will be demonstrated in the cynomolgus monkey; the biodistribution of Tethosome DNA
and therapeutic protein expression will be determined in key organs including the liver, spleen, lung, and kidney
by qPCR and in-situ hybridization; and 3. The GLP manufacture of Tethosome therapeutics will be initiated in
preparation for future IND-enabling studies with the goal of producing 100-150 mg of GLP product for intravenous
delivery.

Public health relevance
Narrative Engage Bio’s novel non-viral expression system for enhancing the level and duration of transgene expression will provide a significant advancement in specificity and expression level compared to existing gene therapy methods for the treatment of both liver cancer and hemophilia. Once the effectiveness and advantages of the platform have been demonstrated, Engage will partner with pharmaceutical and biotech companies to undertake co-development of novel gene therapies and/or license our technology to these companies, thus mitigating the cost of new drug development by using wild type genes for which there are no patents, and for which no license is needed.